Developing new mouse models of andropause for ADRD research

PROJECT SUMMARY/ABSTRACT
Aging and AD are associated with a decline in sex hormones. Approximately 40% of men over 45 years old
suffer from low androgen levels. Endocrine aging in men, termed andropause, is characterized by age-related
declines in androgens (such as testosterone). These declines in androgens are associated with increased AD
risk and cognitive decline. Despite advances in menopause models, models of endocrine aging in males
(andropause) have been stalled for over a century and are limited to gonadectomy. Gonadectomy causes almost
a complete loss of androgens, and thus does not accurately mimic reduced androgen levels observed in
andropause in men. Lack of more accurate models of andropause that more closely mimic the human hormonal
profile is a critical technical gap that is severely limiting the fields of aging and dementia. Our long-term goal is
to develop mouse models of dementia that more accurately reflect the hormonal environment in humans and
thus increase the translational potential of therapies that are tested in these models. The objective of this
proposal is to develop two new mouse models of andropause. First, we will determine the time course of natural
endocrine aging in WT mice and several mouse models of ADRD (Aim 1). Next, we will model endocrine aging
in males via gonadectomy and hormone replacement with gradual decreasing of androgen replacement over
time (Aim 2). For a non-surgical model of andropause, we will determine if a reproductive toxin can be used to
induce gradual androgen loss in male mice (Aim 3). For each model, we will assess aging phenotype (decreased
strength, reduced activity, increased anxiety, and impaired memory) and AD neuropathology. We predict that
mice with low androgen levels will exhibit a more accelerated aging phenotype and increased AD
neuropathology. This would represent the first ever models of andropause with carefully controlled, gradual
hormone loss. Without these new, improved models of andropause, the field will continue to test therapeutics for
AD in male mice with an endocrine status does not match that of aging men. This hinders the translational
potential of these therapies. Our new models have the potential to transform the aging field.

Public health relevance
PROJECT NARRATIVE Low androgen levels (andropause) in men increases risk of Alzheimer’s disease and related dementia. Models of andropause have been stalled for over a century and are limited to gonadectomy, which does not accurately mimic reduced androgen levels observed in andropause in men. The lack of models of andropause that more closely mimic the human hormonal profile is severely limiting the fields of aging and dementia; thus, the objective of this proposal is to develop two new mouse models of andropause.